Mechanisms of repressive interactions between developmental gene regulatory networks

Cells acquire their unique identities during development through the progressive emergence of distinct
transcriptional programs. These transcriptional programs can be viewed as dynamic networks of interacting
genes known as gene regulatory networks (GRNs). GRNs have been well studied for their positive role in
activating the expression of genes that endow cells with their specialized properties; however, it is now apparent
that an equally important function of these networks is to exclude other, potentially alternative, transcriptional
programs. Repressive interactions of this kind play a widespread, fundamental role in determining cellular
identities in organisms as diverse as invertebrates and mammals. They are also important in the context of
regenerative medicine. The direct reprogramming of somatic cells by lineage-specific transcription factors (TFs)
is accompanied by the comprehensive silencing of pre-existing transcriptional programs. Despite the pivotal role
that repressive interactions between transcriptional networks play in both embryonic cell fate specification and
somatic cell reprogramming, the underlying mechanisms are poorly understood.
We will address this important problem using the sea urchin, a prominent experimental model for the
analysis of developmental mechanisms and for GRN biology. One of the best characterized sea urchin GRNs
underlies the development of cells that form the skeleton. A key component of this network is Alx1, a lineage-
specific TF that provides direct, positive inputs into many genes that support skeletogenesis. In parallel with its
positive role, Alx1 represses potential, alternative transcriptional programs that are ordinarily restricted to
surrounding non-skeletogenic mesoderm (NSM) cells. Perturbation of Alx1 function in skeletogenic cells results
in the ectopic deployment of NSM GRNs in these cells and causes them to adopt NSM fates. The repression of
NSM GRNs by Alx1 thus provides an outstanding opportunity to uncover mechanisms by which transcriptional
networks interact with one another, thereby ensuring the emergence of unique cellular identities.
To dissect the mechanisms underlying this GRN interaction, I will begin by defining key spatial and
temporal aspects of NSM GRN repression by Alx1, using both quantitative methods and spatial gene expression
analysis to characterize changes in gene expression that occur after perturbing Alx1 function (Aim 1). Next, I
will explore the hypothesis that Alx1 directly represses NSM genes by using fluorescent reporter constructs and
transgenesis to dissect cis-regulatory elements of these genes (Aim 2). Finally, I will test the hypothesis that
Alx1 controls a cell-autonomous unresponsiveness to Notch/Delta signaling, a pathway that drives NSM
specification during normal development (Aim 3). These studies will shed light on the mechanisms by which
Alx1 represses NSM GRNs. More broadly, they will lead to a better understanding of interactions between
transcriptional networks that regulate cell identity.

Public health relevance
Cells acquire their unique identities during embryonic development through the progressive emergence of distinct programs of gene expression. A critically important feature of this process is the ability of one program of gene expression to block other, potentially alternative, programs. This project examines the molecular mechanisms that underlie repressive interactions between gene expression programs, with important implications for understanding how different cell types arise during development and for therapy-based cell engineering.